Sex Hormone Receptor Component And The Cell Genome

Project/Summary Abstract
Significant advances in our mechanistic understanding of progesterone receptor (PR) mediated transcription
are inextricably tied to our structural knowledge of the core transcriptional complex through which PR along
with its coregulators (Coregs) control target gene transcription. Pioneering the use of single-particle cryo-
electron microscopy (cryo-EM) in steroid hormone nuclear receptor (NR) biology, we recently revealed the
quaternary structure of the transcriptional complexes for the estrogen receptor (ERa) and androgen receptor
(AR), which along with PR comprise the “NR triad” of sex steroid hormones that govern mammalian
reproductive biology. Unlike ERa and AR, PR is composed of the PR-A and PR-B isoforms that mediate both
distinct and overlapping progesterone transcriptional responses in physiological and pathophysiological
contexts. Accordingly, a comprehensive understanding of the transcriptional response to progesterone can
only occur through a structural characterization of the core transcriptional complexes of the homodimer and
heterodimer configurations of these PR isoforms. Therefore, Aim 1 will use cryo-EM and complementary
structural proteomic approaches to solve the quaternary structure of the core Coreg/transcriptional complex
for the PR-A homodimer bound to DNA. Significantly, we have determined the core Coreg/transcriptional
complex for the PR-B homodimer. Not only has this structural information provided critical insights into the
unique assembly mechanisms by which PR-B recruits primary and secondary Coregs during transcriptional
complex formation but reconfirms our ability to successfully execute the structural studies in Aims 1 and 2.
Importantly, this technology presents a unique opportunity to investigate the contribution of the intrinsic
disordered region of the activation function 1 (AF1) in PR during Coreg/transcriptional complex assembly.
Despite its importance in PR mediated transactivation and its potential for therapeutic targeting, the AF1
domain (unlike the ordered AF2) is understudied due to its disordered topology. Using a PR AF1 mutant, Aim
2 will use cryo-EM and allied structural methods to assess the contribution of AF1’s structural disorder in the
dynamic assembly mechanisms that underpin Coreg recruitment by PR-B to the nucleating transcriptional
complex. This aim will be complemented by Aims 3 and 4, which will determine the transcriptional functional
role of PR’s AF1 disordered structure using innovative cell-free/cell-based investigations and a CRISPR-
engineered mouse model respectively. Collectively, these transformative investigations will: (i) furnish a much
needed structural and mechanistic framework to explain the PR isoform-specific functional differences in
physiological and pathophysiological contexts; (ii) define the structure-function relationship of AF1’s flexibility in
dynamic interactions with multiple Coregs at the cell- and whole organism-level; and (iii) offer new
opportunities to modulate PR isoform activity to clinically treat a spectrum of progesterone-dependent
gynecologic disorders.

Public health relevance
Project Narrative This research program will delineate the structural and molecular mechanisms by which hormone-bound progesterone receptor regulates gene transcription that underpins female reproductive processes. Innovative cryo-electron microscopy and structural proteomic approaches, together with inventive in vitro and cell-based assays and state-of-the-art engineered mouse models will elucidate the unique structural importance of a defined functional domain in the progesterone receptor. Accordingly, research outcomes from these investigations will significantly advance our fundamental understanding not only of progesterone control of female reproductive biology but also gynecologic disorders that lead to infertility and other reproductive morbidities.